Genetics of Asthma Sub-Phenotypes Impact Gene Regulation in Cell-Specific Patterns

PROJECT SUMMARY/ABSTRACT
This proposal outlines an integrated research and career development plan for Nathan Schoettler, MD, PhD to
conduct training in the laboratory of Dr. Carole Ober and transition to an independent academic position by
establishing a research program at the interface of genetics and immunology with a NIH mentored career
award (K08). The PI recently completed an NIH T32 fellowship (T32 HL007605) and is trained in the fields of
immunology, genetics, molecular biology and cell biology, and during the time of this K08 award, the PI will
receive additional academic guidance from additional co-mentors (Dr. Dan Nicolae and Dr. Anne Sperling) and
advisors (Dr. Julian Solway, and Dr. Hae Kyung Im) at the University of Chicago. The career development plan
is designed to equip the PI with the necessary knowledge and skills in statistical genetics and cellular
immunology for a successful transition to an independent academician, and R01 funding. The overall goal of
the proposed research is to elucidate the role of genetic variation in regulating the expression of genes in
specific lung cell types that play a critical role in asthma. Asthma is a complex genetic disease with high
heritability, yet how genetic variation influences pathobiological mechanisms, or endotypes, in asthma has not
been resolved. Studies conducted by the PI during his post-doctoral T32 phase demonstrated that childhood-
onset and adult-onset asthma have both shared and distinct genetic risk loci (Lancet Resp Med 2019). The PI
furthermore showed that human lung tissue resident memory T cells, a subset of T cells that do not circulate in
the blood, are programmed differently and derived from a separate pool of progenitor than lung-draining lymph
node memory T cell subsets (Comm Biol, in press), and they rapidly increase the expression of key asthma
cytokines when activated. This K08 research proposal tests the overall hypothesis that specific asthma sub-
phenotypes have shared and distinct genetic risk factors and that these risk loci mediate effects in cell-specific
manners that perturb gene expression and disease risk in unique ways. Aim 1 will test the hypothesis that
clinically important asthma sub-phenotypes share a set of genetic risk variants but also have additional, sub-
phenotype-specific genetic risk loci. Aim 2 will test the hypothesis that a subset of asthma-risk loci will harbor
variation that has unique effects on gene expression in lung tissue resident memory T cells that have not been
revealed in other tissues or cell types. Aim 3 will test the hypothesis that asthma sub-phenotypes have different
sets of risk loci that influence gene expression in asthma-relevant cells from lungs, specifically T cells, smooth
muscle cells and epithelial cells. The goals of this research will be achieved by integrating genome-wide
association studies with expression quantitative trait loci identified in airway cells with and without asthma-
relevant exposures, and lead to a mechanistic understanding of how genetic risk variants influence cellular
responses, ultimately revealing potential therapeutic targets. This career award will accelerate the transition for
Dr. Schoettler to an independent physician-scientist and the acquisition of competitive R01 funding.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because asthma is the most common chronic respiratory illness and the most common chronic childhood illness. Genetics contribute to asthma risk, although the how they affect specific cell types in asthma is not well understood, and this project will delineate genetic contributions to important subsets of asthma and determine their effects in cell types pertinent to asthma. This project is relevant to the NIH mission because it seeks knowledge about asthma with a goal of enhancing health, lengthening life and reducing illness and disability.